ALCOHOL ABUSE TREATMENT OUTCOMES IN MANAGED CARE

APPLICANT'S ABSTRACT: We will draw upon the existence of an outcomes information system developed in conjunction with a national behavioral managed care organization to assess the effects of variations in treatments approaches and specific strategies on various functional outcomes and costs. We will collect functional outcomes on about 2700 cases at 6, 12, and 18 months. We will analyze the contribution of patient characteristics in explaining treatment outcomes (specifically examining the effects of discontinued treatment as part of the analysis of treatment effectiveness). Using special survey information and data taken from administrative records, we will analyze the contribution of provider characteristics (e.g., training, experience, alcohol/substance abuse history) and the contribution of treatment approaches (e.g., number and types of sessions and duration of treatment) in explaining the functional treatment outcomes, (i.e., other than costs). Using, the full data set (with baseline measures and utilization data), we will calculate the medical and alcohol/substance abuse costs of alcohol and alcohol/substance abuse treatment and the costs of all medical treatment by analyzing MCC and its parent CIGNA claims data. We will estimate the relationship between various measures of patient characteristics, including, baseline functional status, and each of the outcome measures, using various forms of regression. These regressions will use the logistical form when the outcome variable is expressed as a dichotomous variable and OLS (ordinary least squares) for continuous variables. We will use these analyses as a base from which to test the explanatory power of various treatment variables by adding them to the predictive equations in different combinations. Finally, we will test the potential for interactions between client characteristics & treatments. The proposed analysis will examine three sets of use and expenditure variables: (1) the use/expenditures for all alcohol/substance abuse services; (2) the use/expenditure of all alcohol/substance abuse related services (including, those in (1); and (3) the use/expenditure of all services. We will examine the last two to see if alcohol/substance abuse treatment of a particular type is partially or fully offset by changing medical treatment patterns. We distinguish between alcohol/substance abuse related costs and total health care costs because the causal linkages to all health care use are weaker and because of a concern over increased noisiness in the aggregate numbers. As a result, we expect less precision in category (3) (all health care expenses) than we do for either (1) (alcohol/substance abuse treatment) or (2) (use/expenditure of alcohol/substance abuse related services).